Identifying Cellular Intraspinal Electrophysiological Features of "Spinal Shock"

Project Summary and Abstract
This project aims to identify the electrophysiological characteristics of spinal motor neurons during the recovery
stages following a spinal cord injury (SCI) in mouse models. Capitalizing on preliminary experiments with soft,
stretchable hydrogel microelectrodes, the study will employ these tools to conduct intraspinal recordings from
the ventral areas of the lumbar segment in awake, behaving mice. By leveraging the advantageous capabilities
of these microelectrodes, we plan to capture precise, real-time electrophysiological signals from motor neurons
and correlate these patterns with observed behavioral changes throughout the recovery process. This project
will enable intraspinal electrophysiology recordings from motor neurons, capturing key electrophysiological
signals across various phases of spinal shock recovery, including areflexia, transition, and hyperreflexia. The
project is structured into two primary aims: Aim 1 focuses on optimizing intraspinal electrophysiological recording
from motor neurons in awake, behaving mice, across activities such as resting, walking, and running over
extended periods. Aim 2 will expand this approach to monitor and analyze electrophysiological properties
throughout different recovery phases post-SCI. This aim involves monitoring motor neuron activities in SCI-
affected mice to assess how these activities correlate with reflex responses and behavioral assessments, to
distinguish recovery-related neuronal changes. Successfully completing this project is expected to enhance our
understanding of neuronal dynamics during spinal shock and recovery, potentially informing new therapeutic
strategies for SCI rehabilitation.

Public health relevance
Project Narrative This project aims to enhance our understanding of neural recovery mechanisms following spinal cord injuries (SCI) by using hydrogel microelectrodes to monitor motor neuron activity in mouse models. By correlating electrophysiological data with behavioral changes during SCI recovery, the findings from this study could enhance therapeutic strategies. This research offers insights that may lead to more effective interventions for SCI, a condition affecting thousands of individuals annually, ultimately aiming to improve patient outcomes and quality of life.